Induction of protective IL-10- producing B and T cells by defined subsets of resident intestinal bacteria

Dr. Sartor blends his internationally recognized expertise in host-microbial interactions and use of gnotobiotic
mice with highly complementary cutting-edge experts in genome science (Shehzad Sheik, Terry Furey);
molecular microbiology and bioinformatics (Anthony Fodor, Jeremiah Faith, Niels van der Lelie); metabolomics
(Kun Lu); molecular predictors of clinical outcomes (Ted Denson, Rebekah Karns) and the considerable
resources of Cores A and B to identify key members of protective resident bacterial species that preferentially
induce IL-10-associated protective immune responses in novel gnotobiotic and humanized models of chronic
experimental colitis and predict clinical outcomes in established cohorts of Crohn’s disease (CD) patients.
Hypothesis: Subsets of resident intestinal bacteria activate protective IL10- associated immune responses in
LP regulatory B and T lymphocytes and metabolites that mediate mucosal homeostasis and predict disease
progression and complications in CD patients. We address this hypothesis through 3 complementary Aims:
Aim 1: Identify resident bacterial species that selectively induce IL10- producing regulatory LP B and T
cells and protect against experimental colitis (supported by Core A).
Hypothesis: Subsets of resident bacteria selectively activate IL10-production by LP B and T cells and metabo-
lites that mediate mucosal homeostasis. Identified bacterial strains will prevent and reverse chronic exp. colitis.
Aim 2. Identify mechanisms of protection of bacterial species capable of reversing established colitis
Hypothesis: Key protective bacterial species activate immunological and metabolic pathways that directly
suppress TH1/17 immune responses and pathogenic bacterial subsets to prevent and reverse chronic colitis.
2A. Identify metabolite profiles of protective bacterial strains and test their protective function.
2B. Determine the ability of protective strains to normalize luminal and mucosal dysbiotic bacterial profiles.
2C. Identify protective immunologic pathways induced in IL10+ LP T and B cells by protective bacterial strains.
Aim 3. Determine whether protective bacterial species and LP cell transcriptional signatures predict
disease progression and post-operative recurrence in phenotyped adult and pediatric CD cohorts.
Hypothesis: Protective bacterial species and IL10-associated transcriptional pathways identified in mice
provide novel predictors of disease progression and complications in defined CD patient cohorts.
This highly innovative and clinically relevant study will yield unique insights into immunologic, metabolic and
microbial mechanisms by which resident bacterial subsets mediate mucosal and microbial homeostasis,
predict clinical CD progression, complications and ultimately, characterize novel therapeutic bacterial species.

Public health relevance
PROJECT NARRATIVE (PROJECT 2) Abnormal balances of beneficial and detrimental resident intestinal bacteria (dysbiosis) drive the aggressive immune responses of Crohn’s disease and ulcerative colitis, however the function of these dysbiotic bacteria have not been evaluated by detailed mechanistic studies. This project will identify dominant protective resident bacterial species and their ability to predict clinical outcomes, including developing complications, progression of disease and recurrence of disease after intestinal resection, in 2 well characterized, prospectively evaluated Crohn’s disease patient cohorts. A long term goal is to identify and characterize novel resident intestinal bacterial consortia for individualized treatments.